Fecal Microbiota Transplant National Registry

PROJECT SUMMARY
Fecal microbiota transplantation (FMT) is an established treatment for patients with recurrent Clostridioides difficile
infection (CDI). Although most patients with CDI can be successfully treated, the subset of acutely ill patients with severe
and fulminant CDI is a much greater challenge, with high rates of colectomy and mortality. Furthermore, a variety of
safety concerns remain for FMT. The risk of transmission of harmful microbes is highlighted by recent reports of
transmission of multi-drug resistant organisms and enteropathogenic E. coli (EPEC). In addition, although most work has
focused on bacteria, FMT also transfers non-bacterial microorganisms, and the clinical impact of these microbes may be
important in fully understanding the clinical implications of FMT. Because the gut microbiota also plays a role in the
pathogenesis of chronic medical conditions (e.g., diabetes, cancer, heart disease), FMT has the potential to cause
chronic conditions that might take years to manifest clinically. Finally, the field is rapidly evolving with the development
of commercial products formulated with live microorganisms, known as live biotherapeutic products (LBPs). Thus,
critically important questions regarding the real-world safety and effectiveness of FMT and LBPs remain unanswered.
The FMT National Registry is a uniquely suited resource to study these key issues. The Registry includes 32 North
American sites (and 19 additional centers pending) with an established infrastructure to collect clinical data on FMT
donors and recipients and a separate portal to collect information from FMT recipients. The Registry’s link to an
independent biobank also provides a rich source for studying manipulation of the gut microbiota in humans.
Our first specific aim is to expand knowledge on the long-term safety and effectiveness of FMT by A) continuing
systematic collection of clinical metadata up to 10 years post-FMT to better define safety, including risk of developing
chronic medical conditions, with incidence rates for predefined chronic conditions in Registry participants compared
with a control group of patients from a national database with multiply recurrent CDI not treated with FMT; B)
determining real-world estimates of effectiveness of FMT and LBPs to treat hospitalized patients with severe/fulminant
CDI and identify factors associated with cure; and C) expanding the registry to include new LBPs, assessing effectiveness
for CDI as compared to FMT in real-world populations and examining off-label use of LBPs for indications beyond CDI.
The second specific aim is to characterize the potential value of shotgun metagenomics sequencing (SMS) and data
analytics as a platform technology to identify and characterize potentially harmful microbes transmitted by FMT or LBPs
by first determining the sensitivity and specificity of SMS to identify and characterize bacterial pathogens using the
emerging pathogen, atypical EPEC (aEPEC) as a prototype. Genotype-phenotype analyses will be performed using a
combination of in vitro bioassays and whole genome sequencing. The sensitivity and specificity of SMS to identify these
strains and their virulence genes will then be determined by fecal spiking experiments. Additionally, studies will be
performed to characterize the impact of FMT/LBP therapy on the resistome and transmission of non-bacterial microbes
(virome, mycobiome) with SMS in patients treated for severe/fulminant CDI.

Public health relevance
PROJECT NARRATIVE Fecal microbiota transplantation (FMT) is an established treatment for patients with recurrent Clostridioides difficile infection (CDI), but its role in treating acutely ill patients with severe or fulminant CDI is uncertain. Important safety concerns also remain around FMT, including the potential for transmission of harmful microorganisms or possible development of chronic conditions such as diabetes or heart disease due to changes in gut microbes resulting from FMT. This research will help determine if FMT has a role in the treatment of acutely ill hospitalized patients with severe or fulminant CDI, assess techniques to identify potentially harmful microorganisms that may be transmitted by FMT, and see if chronic conditions develop more commonly years after FMT.